Probing chemical dynamics and catalytic mechanisms in metalloenzymes with advanced X-ray spectroscopy techniques

Project Summary/Abstract
The goal of this proposal is to develop new methods for X-ray absorption spectroscopy (XAS) that can use
the ultra-short, femtosecond pulses from X-ray free electron lasers (XFELs) to help us understand the
mechanism of redox-active metalloenzymes by following the catalytic reaction, in real time, at room
temperature. Unlike X-ray emission spectroscopy (XES), which has been used at XFELs, XAS is much more
versatile for studying the electronic structure with X-ray near edge spectroscopy (XANES) and extended X-ray
absorption fine structure (EXAFS) for determining metal-metal, and metal-ligand distances. Unlike
crystallography, XAS can be conducted using solution samples and often yields higher resolution for specific
metal-distances than X-ray diffraction. Nevertheless, XAS has so far seen only very limited use for room
temperature time-resolved studies of metalloenzymes using XFELs. The challenges of XAS at XFELs arise
from the requirement to scan a wide energy range of incident X-rays; significant shot-to-shot spectral, temporal,
and intensity fluctuations in the pulses; and data collection of dilute metalloenzyme systems with limited sample
volumes. While progress has been made overcoming these impediments, the most important issue that has not
been addressed adequately until now is how to mitigate the contribution of background scattering, which leads
to very poor S/N ratios. This is largely because the high count rate of photons at XFELs leads to pulse pile-up
and does not allow us to use the energy discriminating, single-photon counting detectors that are usually
employed in synchrotron facilities to discriminate the signal from background photons at XFELs.
In this proposal, we will focus on the remaining obstacle to XAS at XFELs by minimizing background
scattering through designing and building a robust and versatile spectrometer, with a large solid angle and
energy resolution of ~10 eV, to discriminate between the background scatter and signal photons and capture
the entire metal Ka fluorescence from the metal, which will be collected using a position-sensitive detector. This
instrument will be tested using model compounds and then will be used to collect time-resolved XANES and
EXAFS data from two important metalloenzymes: the Mn4Ca complex in photosystem II involved in the oxidation
of water to oxygen, and the ribonucleotide reductase class of enzymes with binuclear Fe/Fe, Mn/Fe, or Mn/Mn
active sites involved in the conversion of ribonucleotides to deoxy-ribonucleotides, the building blocks of DNA.
In PS II, which will be triggered by light flashes, we will focus on the time-points in the S3 to S0 transition
reached after illumination with three flashes, the last step in the catalytic cycle where the critical step of O-O
formation occurs. The XANES and EXAFS data from these timepoints will be important for unravelling the
mechanism of the photosynthetic water oxidation reaction. In RNR, which will be triggered by in situ O2 addition,
we will focus on the intermediate state, known as ‘X’, which is transiently generated and whose exact structure
is not known and has been the subject of much study.

Public health relevance
Project Narrative Metalloenzymes are involved in catalyzing many reactions that are of critical importance to health, using transition metals such as Fe or Mn in their active sites. The introduction of X-ray free-electron lasers has made it possible to follow these enzymatic reactions at room temperature in real time as the reaction proceeds. Development of X-ray absorption spectroscopy methods that make use of this novel transformative tool is important for understanding the dynamics of the metal sites and the mechanisms of these reactions.